Technologies and Resources for Core Laboratories

The Technology and Resources for Core Laboratories Core (Technology Core) of the West Virginia Clinical and
Translational Science Institute (WVCTSI) supports research infrastructure critical for rapid translation of
innovation to positively impact the health of West Virginians. Importantly, the Technology Core leverages the
significant previous IDeA investment in West Virginia, while bringing exciting innovation to support clinical and
translational (C/T) investigators’ efforts. Resources described in this Core are essential in providing
infrastructure to engage and train C/T scientists with a focus on essential pipeline development as well as
diversity of the future generation of C/T investigators. The Technology Core will leverage a strong statewide
infrastructure through partnerships with West Virginia University (WVU), Marshall University (MU), NIOSH and
the WV DHHR that has been strengthened during the previous funding period. New technical capacity will be
provided to investigators and their trainees to support interrogation of current, acute, problems as well as being
positioned to take on emerging and future public health crises. The capacity to be nimble in the scope and focus
of research that can be supported, both technically and intellectually, is central to the Core. The specific aims
that will operationalize our progress towards these goals include to: (1) develop and optimize molecular and
protein-based diagnostic assays and support lead compound optimization via an automated pipeline in the newly
established Molecular Medicine Laboratory (MML), (2) enable investigations of the health effects of inhalation
exposures relevant to rural communities via the state of the art inhalation toxicology facility (iTox) and (3) support
translational investigations of pathogens underlying emerging infectious diseases. Focus across the Technology
Core is provided by tethering all activities to WVCTSI priority health areas to avoid diffusion of investment and
energy, and maximize investment to achieve significant and measurable outcomes. Relevance is obtained by
absolute diligence in the design and focus of each aim connecting to a clinical application. In combination, this
results in impact on our understanding of specific diseases of interest, and the potential to impact positively on
the health of West Virginians while contributing to the broader scientific community.